Shared Resource Management

PROJECT SUMMARY – SHARED RESOURCE MANAGEMENT (SRM)
The University of Wisconsin Carbone Cancer Center (UWCCC) provides scientific and administrative oversight
and allocates funds from the Cancer Center Support Grant (CCSG) and other sources to support 12 Shared
Resources (SRs). These SRs serve the vast majority of UWCCC members and advance the Center’s strategic
research initiatives. Each SR is led by an expert faculty leader, who is a UWCCC member, and a highly
experienced facility manager. Dr. Jim Shull (Cancer Genetic and Epigenetic Mechanisms (GEM)) has served
as Associate Director for Shared Resources (ADSR) since 2009, and Ms. Dawn Church has served as Assistant
Director for Shared Resources (AsstDSR) since 2015. The mission of our Shared Resources Management
(SRM) team is to provide UWCCC members with access to cost effective, state-of-the-art research infrastructure
and world class expertise that enable cancer-focused research along the entire basic to community/population
research continuum. Aim 1 is to establish, manage, and support SRs that advance the research of the UWCCC
membership. SRM engages UWCCC leadership to match the services provided by our SRs to the defined needs
of our members; to maximize cost effectiveness; and to ensure that our SRs evolve in a manner that aligns with
UWCCC’s strategic priorities. SRM strives to attain management and operations consistencies across all SRs.
Aim 2 is to engage UW leaders to secure institutional support for the UWCCC SRs. SRM works closely with
leaders within the School of Medicine and Public Health (SMPH) and other UW leaders to secure/sustain
institutional support, minimize redundancies in services existing across the UW campus, and leverage the
immense scale of the UW research enterprise when negotiating with equipment, supply, and service vendors.
Aim 3 is to develop and implement effective marketing and evaluation tools and strategies. These tools and
strategies educate our membership and the entire UW research community of our SRs’ services, technical
capabilities, and expertise, and inform our SR faculty leaders and managers and UWCCC leadership of the value
of the services provided by our SRs and the changing needs of our member users. Approximately 90% of all
UWCCC program members utilized one or more of our SRs during the 2017-2021 CCSG cycle. Member SR
users collectively held 735 cancer-relevant research grants totaling $75.7 million on December 31, 2021,
including 130 awards from the National Cancer Institute (NCI) totaling $26 million in annual direct costs. Survey
data indicate our SRs are highly valued by the UWCCC and broader UW research communities and virtually all
our members indicate their research programs would be severely compromised if our SRs did not exist. Our SRs
received the aggregate merit rating of outstanding at the 2017 review of the CCSG. Since that review, the
UWCCC and our UW partners have established 3 new SRs, reorganized/expanded/enhanced all remaining SRs,
and invested more than $32 million to support SR operations, enhance SR infrastructure, and optimally align SR
capabilities to the needs of our members.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.